Telemedicine Preparation for Older Adults with Type 2 Diabetes

During the COVID-19 pandemic, many primary care appointments were converted to telemedicine.
Telemedicine appointments may be especially beneficial for patients who are at high risk for COVID mortality,
such as older adults, African Americans, and patients with type 2 diabetes. Numerous studies have found
telemedicine can be an effective venue for diabetes care. Unfortunately, such interventions often assume that
patients already have internet-capable devices, reliable internet service, and basic digital skills. Many patients,
especially older patients and African Americans, lack the digital skills needed for telemedicine. Unfortunately,
the net result is that those at highest risk for chronic diseases and their complications are often least able to
take advantage of telemedicine. We propose a digital skills training intervention comprising essential basic
skills to participate in a telemedicine appointment for older (age 50-70 years) mostly African American primary
care patients with type 2 diabetes who already own an internet-capable device but have never had a
telemedicine appointment. The intervention's goal is to prepare patients to have a successful telemedicine
appointment. Patients will first be assessed for skills and then receive customized digital skills training through
a community-based organization. Participants will also be scheduled to have a virtual diabetes management
appointment within 6 months.
For Specific Aim # 1, we will measure whether or not patients referred to the telemedicine training intervention
complete a telemedicine appointment within 6 months. In Specific Aim # 2, we will interview patients and
analyze interview transcripts to assess their experience with telemedicine. Patients who successfully
completed a telemedicine appointment will be asked about their satisfaction with both the telemedicine training
intervention and their telemedicine appointment. Patients who enrolled in the telemedicine training intervention
but either did not complete a telemedicine appointment and/or did not complete telemedicine training will be
asked about their barriers and how the telemedicine training intervention could better meet their needs.

Public health relevance
During the COVID-19 pandemic, many routine primary care appointments were successfully converted to telemedicine appointments. Unfortunately, many patients, particularly as older adults and African Americans, lack the digital skills needed for telemedicine success. We propose an intervention to prepare older, predominantly African American patients for telemedicine appointments for routine care of type 2 diabetes. We will measure whether patients who complete the telemedicine training program are able to have a successful diabetes management appointment via telemedicine within 6 months. We will also interview patients about their experiences with the telemedicine training program and appointments.